Preclinical studies for the immunoprevention of multiple myeloma

PROJECT SUMMARY
Smoldering multiple myeloma (SMM) is a premalignant condition present in 1 in 200 people of northern
European ancestry and is even more prevalent in those of African ancestry. It progresses with a variable
frequency to symptomatic multiple myeloma (MM) associated with anemia, bone lesions and renal failure.
Patients with SMM at high risk of progression (>20% per year) are currently being enrolled in diverse clinical
trials using therapies that have been approved for the treatment of symptomatic MM. For the vast majority of
patients with SMM, that have a lower risk of progression (e.g., 2-10% per year), there are no recommended
interventions and a scarcity of clinical trials. In order to develop safe, low-risk clinical trials for these patients,
there is the need for faithful, orthotopic, immunocompetent pre-clinical models that recapitulate the life-history
of SMM to MM transition in a reasonable time frame and that can be used to assay different interventions.
We have developed the clinically predictive, fully immunocompetent Vk*MYC and Vk*MYChCRBN mouse model
of MM that can be used to study the slow progression from SMM to MM, as well as the effects of interventions,
including treatments that incorporate immunomodulatory thalidomide analogs (IMiDs) that requires human
cereblon (CRBN). By analyzing cohorts of Vk*MYC mice maintained in the USA or Italy we identified a key role
for the gut microbiome in the progression of MM in both mice and humans. Mechanistically certain microbiota
can stimulate TH17 cells in the gut to migrate to the bone marrow and stimulate eosinophils to secrete IL6,
stimulating SMM progression.
Based on exciting preliminary data we will examine how various factors can lead to an inflamed bone marrow
microenvironment (e.g., diet, microbiome, systemic inflammation, clonal hematopoiesis) that can accelerate
SMM and the ability of anti-inflammatory immunoprevention approaches including NSAIDs, NLRP3 inhibitors,
IMiDs, IL18 antibody to delay or prevent this progression. Overall, these data will provide strong pre-clinical
rationale to support clinical trials of immunoprevention approaches for patients with SMM.

Public health relevance
PROJECT NARRATIVE Smoldering multiple myeloma is a pre-malignant condition present in 1 in 200 adults of European ancestry and is even more prevalent in those of African ancestry. There is a critical need to develop safe, low-risk interventions to prevent its progression to malignant multiple myeloma associated with anemia, bone lesions and renal failure. This project will address this need by developing faithful and predictive pre-clinical mouse models to study immunoprevention of the progression to multiple myeloma